4-Nonylphenol and the Mechanism of Alzheimer's Disease

Project Summary
Alzheimer's disease (AD) is a progressive brain disorder associated with continuous decline
in thinking that leads to loss of behavioral, social, and cognitive skills. Memory loss is the key
symptom of AD. It is a major public health concern and a tremendous economic and societal
challenge. Minority communities, such as Hispanic and Black, are disproportionately affected by
this disease. AD is a neurodegenerative disease, and its pathology is characterized by extensive
neuronal loss and the deposition of two abnormal protein structures, amyloid plaques (composed
of amyloid -protein) and neurofibrillary tangles (composed of the microtubule-associated protein,
Tau) in the affected brain regions. Aging is the most consistent risk factor in developing AD and
recent evidence suggests that environmental factors play a significant role in this process.
4-
Nonylphenol (4-NP)
is an endocrine-disrupting compound (EDC) and an environmental pollutant
that has recently been implicated as a risk factor for AD and AD-related dementia. 4-NP
has been
of environmental concern for decades due of its toxicity, estrogenic properties, and widespread
contamination in the environment including water, air, and soil.
Research from our laboratory
demonstrates that 4-NP disrupts microtubules (MT) and alters the localization and expression of
Tau, the MT-associated protein. The Tau protein and its phosphorylation status has been shown
to be linked to the initiation and progression of AD and AD-related dementia. Earlier studies have
exhibited that 4-NP exposure produces learning and memory impairment in adult rats and causes
behavioral and cognitive deficits in offspring when exposed prenatally. Our preliminary studies
indicate that 4-NP causes a substantial neuronal loss in zebrafish embryos. Altogether, these
results point towards the adverse effects of 4-NP on neuronal development, neurodegeneration,
and learning/memory. Therefore, our hypothesis is that exposure of 4-NP can induce AD-like
pathology and behavior by disrupting the cytoskeleton and inducing tau hyperphorylation and
protein aggregation. Both cell cultures and a zebrafish model will be used to conduct the study.
We will test our hypothesis by addressing the following two specific aims. In Aim-1, we will
determine the
mechanism of 4-NP-induced cytoskeletal disruption and Tau
hyperphosphorylation in a cell culture
model. The goal of Aim-2 is to utilize the zebrafish model
to study the effects of 4-NP on learning and memory deficits. It is anticipated that the proposed
study will delineate the mechanism by which 4-NP induces AD and related dementia, which affect
the Hispanic population in U.S./Mexico border communities disproportionately.

Public health relevance
PROJECT NARRATIVE. Alzheimer’s disease (AD) is a leading cause of dementia in the U.S. and a major public health concern. Aging is the most consistent risk factor in developing AD and recent evidence suggests that environmental factors could play a significant role in this process. The proposed study will investigate the potential role of 4-Nonylphenol (4-NP), a ubiquitous environmental toxicant in inducing AD-related pathogenesis and, thus, is relevant to the public health. It is anticipated that the work proposed in this application will bring awareness to the Hispanic population in US/Mexico border community, who are affected disproportionately by AD.